STEREOTACTIC INJECTION OF HERPES SIMPLEX THYMIDINE KINASE VECTOR PRODUCER CELLS

The purpose of this study is to determine the safety and efficacy of stereotactic injections of vector producer cells followed by ganciclovir treatment for recurrent malignant glioma.